Innate NLRC4 signaling controls adaptive immune responses

Project Summary
NLRC4 is a member of the Nucleotide-Binding Domain and Leucine-Rich Repeat Receptor (NLR) family of
cytosolic pattern recognition receptors and is primarily expressed in innate immune cells. The canonical NLRC4
pathway is activated following the recognition of components of Gram-negative bacteria by NAIP proteins
resulting in NLRC4 oligomerization and assembly of the inflammasome complex. Activation of the NLRC4
inflammasome culminates in caspase-1-mediated processing and release of the pro-inflammatory cytokine IL-
1. We have found that NLRC4 plays a protective role in mice challenged subcutaneously with either B16F10
melanoma cells or in a model of influenza A virus infection. In both models, Nlrc4-deficient (Nlrc4-/-) mice had a
loss of effector CD4+ T cells. Generation and maintenance of robust T cell responses relies on T cell interactions
with antigen presenting cells. Evaluation of Nlrc4-/- macrophages and dendritic cells (DC) revealed a
downregulation of AKT1 and FoxO3a phosphorylation, which in turn resulted in the upregulation of the apoptosis-
inducing ligand FasL on Nlrc4-/- myeloid cells that triggered cell death in co-cultured T cells. Importantly, unlike
the canonical NLRC4 pathway, the anti-tumor and anti-viral roles of NLRC4 were inflammasome-independent,
suggesting a novel non-canonical NLRC4 signaling pathway. In this proposal we will expand on these novel
findings and utilize innovate technologies to probe unanswered questions. We hypothesize that endogenous
danger signals activate NLRC4 in myeloid cell, which in turn maintains effector T cell responses by preventing
FasL upregulation. We will define the mechanism by which NLRC4 is activated in antigen presenting cells and
the novel non-canonical pathway through which NLRC4 modifies subsequent T cell responses. We will also
determine what factors downregulate NLRC4 expression and how this downregulation can be exploited by
pathogens and tumors. These studies will identify novel pathways in innate immune cells that can be targeted to
either augment specific anti-tumor or anti-viral responses or inhibit pathogenic T cell responses.

Public health relevance
Project Narrative We will interrogate how the innate immune NLR family member NLRC4 in macrophages and dendritic cells affects T cell responses through the modulation of expression of the apoptosis-inducing ligand FasL. We will further determine mechanisms pathogens and tumors exploit to downregulate NLRC4 expression and evade immune responses. These findings will provide critical insights into the non-canonical NLRC4 signaling pathway and identify novel therapeutic targets that can augment or inhibit specific immune responses.